Essential roles of DAP12 in tau metabolism and inflammation in Alzheimer's disease

PROJECT SUMMARY
Alzheimer’s disease is the most common cause of dementia in the elderly. Recent genetic data strongly suggest
that microglia-mediated innate immune activities may directly contribute to the AD mechanisms at early onset
and/or developmental stage of this disease. Understanding the molecular mechanisms underpinning how
microglia are functionally involved in the pathogenesis of AD is beneficial for the development of new therapeutic
strategies for AD. Our long-term objective is to dissect the function of adaptor protein DAP12 in mediating
complex signals and executing their functions in microglia involved in AD pathogenesis. Our preliminary data
revealed a global effect of DAP12 deficiency in the brain transcriptome of tau P301S mouse, which reverses the
transcriptomic changes featured in the brains of multiple AD transgenic mouse models. We further found that
DAP12 deficiency increased brain tau pathology in tau P301S mice and reduced tau degradation by cultured
primary microglia. Yet, DAP12 deficiency significantly decreased brain microgliosis in tau P301S mice.
Therefore, we hypothesize that DAP12 plays differential roles in tau metabolism and microglia-mediated
inflammation during the pathogenesis of AD. We plan to fully characterize the role of DAP12 in these two AD-
relevant cellular events mediated by microglia and tau seeding/spreading. Finally we will further determine
signaling pathways altered by DAP12 deficiency on cell type specific manner in tauopathy mice.

Public health relevance
PROJECT NARRATIVE Strong genetic evidences suggest that microglia may play a key role in the pathogenesis of Alzheimer’s Disease (AD). DAP12, as an adaptor protein involved in the cross-interaction of signal networks of surface immune receptors in microglia, has been indicated to be a central player in an AD-associated microglia specific module. Our study reveals that DAP12 differentially regulates microglia-dependent tau metabolism and microglia- mediated inflammation, providing us a comprehensive understanding the disease mechanism underlying the fundamental contribution of microglia to the development of AD.